Regulation and function of site-specific protein poly-ADP-ribosylation

PROJECT SUMMARY
Protein ADP-ribosylation (ADPr) is a dynamic, NAD+-dependent post-translational modification. The mammalian
poly(ADP-ribose) polymerase (PARP) proteins that catalyze ADPr target several chemically distinct amino acid
side chain functionalities on hundreds of substrate proteins to mediate a multitude of orthogonal signal
transduction pathways. Adding to this complexity is the potential for ADP-ribose polymer formation, a process
wherein the PARP1/2 and TNKS1/2 enzymes elongate ADP-ribose chains from mono-ADPr sites. Highlighting
the importance of poly-ADP-ribose in physiology and disease are: (i) the expanding clinical utility of PARP1/2
inhibitors to treat DNA repair-deficient cancers, and (ii) TNKS1/2 function in Wnt/b-catenin signaling and
dysfunction in developmental diseases including Cherubism. Aberrant ADPr activity has also been reported as
an underlying cause of cardiovascular and neurogenerative diseases, and these findings have inspired intense
efforts to elucidate PARP substrate profiles, determine PARP regulatory mechanisms, and develop PARP
isoform-specific inhibitors. However, given the liberal deployment of ADPr in cellular signaling and its
topologically complex chemical nature, our understanding of how specific mono- and poly-ADPr sites impact
protein function and elicit distinct biological activities has lagged behind. The proposed work aims to fill this
knowledge gap by developing novel approaches to reconstitute ADPr-mediated signaling events in highly
controlled biochemical and cellular environments. We recently developed a chemoenzymatic strategy to install
serine ADPr onto peptides and proteins with full control over modification site and ADP-ribose chain length.
Using this technology, we identified critical molecular determinants of DNA damage-induced chromatin
remodeling and uncovered specialized functions for nucleosome serine poly-ADPr. We are now in a unique
position to build upon our technologies and address fundamental questions in PARP biology. We will explore
mechanisms that govern poly-ADPr activity and investigate how different modification sites and accompanying
polymer lengths encode for specific biochemical outputs throughout the cell. Such information may guide more
effective strategies to identify and treat diseases that rely on dysfunctional ADPr activity.

Public health relevance
PROJECT NARRATIVE ADP-ribosylation is a post-translational modification that targets hundreds of mammalian proteins and mediates a broad spectrum of biological activities, including DNA repair, transcription, translation, and protein stability. This research program will develop new technologies to study the regulation and function of specific protein ADP-ribosylation events, and investigate mechanisms that enable mono- and poly-ADP-ribosylation to operate in numerous non-overlapping cellular signaling pathways. A more clear understanding of how cells control and employ ADP-ribosylation is becoming increasingly important as PARP inhibitor development efforts and clinical applications continue to expand for the treatment of cancer and other human diseases.